ACTG 243--PHASE II STUDY COMPARING ANTIRETROVIRAL THERAPY ALONE OR WITH ARA-C

This is a randomized open-label study which will compare the efficacy of antiretroviral therapy vs. antiretroviral therapy plus cytosine arabinoside (Ara-C) in the prevention of death during study follow-up in HIV-infected individuals who have developed progressive multifocal leukoencelphalopathy (PML).